Biomedical Studies and Cellular Imaging via Atomic Force Microscopy

We have continued to develop biological atomic force microscopy (Bio-AFM), force sensing platforms, microscopy and spectroscopy methods, and related biosciences. In collaboration with NIH intramural and extramural scientists, we are working toward broader and more insightful applications of these biophysical methods to solve biomedical problems such as malaria and cancer.

The range of biomedical collaborations this year include:

(1) On multifunctional nanomedicine and theranostics with collaborators at NIH and around the world. We have applied Bio-AFM and related methodology to develop novel theranostics (such as precisely targeting and controllable release nanoparticles) and to investigate their anti-cancer and other biomedical properties. We contribute toward sustained development of leading nanomedicine platforms from nanoscale characterization of novel theranostics to preclinical efficacy studies.

(2) On developing a better vaccine toward enhanced immunological response and eventual eradication of malaria. Via Bio-AFM and related bioanalysis, we have investigated the macromolecular structure and nanomechanical properties of many malaria vaccine candidates and related samples with Dr. David Narum (NIAID, NIH) and many colleagues across NIBIB, NIAID, NICHD, etc. Bio-AFM imaging and related advance imaging characterization from single macromolecule to whole cell/tissue can help define new vaccine constructs and biological mechanisms in malaria-causing parasites, mosquitos and humans.

(3) On developing force sensing/monitoring methods and multimodal diagnostic instruments with Drs. Amir Gandjbakhche (NICHD), Tom Pohida (NIBIB) and colleagues with potential benefits to long COVID-19 patients.

(4) Finally in areas of biological membrane and cellular biophysics, e.g. (A) with Dr. Ling-gang Wu (NINDS) and coworkers to better understand synaptic transmission and neuronal communications in brain, (B) with Dr. Dan Sackett (NICHD) on Bio-AFM studies of microtubules interacting with approved or developing anti-cancer drugs and other agents, (C) with Dr. Ralph Nossal (NICHD), Prof. Eileen Lafer and Prof. Rui Sousa (Univ. Texas Health Sciences Center, San Antonio) and colleagues on protein clathrin and assemblies in receptor-mediated endocytosis and intracellular trafficking, (D) with Dr. Andrew Doyle (NIDCR), Dr. Kenneth Yamada (NIDCR), and Dr. Raimon Sunyer (Institute for Bioengineering of Catalonia, Spain) on extra cellular matrix (ECM)-like collagen gels, (E) with Dr. Curtis Meuse (NIST) and coworkers on amyloid-beta fibrils in the Alzheimer's disease.